Coordination of modifications across RNA species

Project Summary
Ribonucleic acid (RNA) is a dynamic molecule marked by diverse enzyme-mediated chemical modifications
that intricately influence its function and destiny within cells. The recognition of enzymes — one kind for
installing specific chemical modification of RNAs and another kind for RNA modification removal—hints at a
purposeful regulatory role in biological processes. While conventional research tends to scrutinize individual
modifications within a single RNA molecule, our investigation has uncovered a broader landscape. This
extends beyond modifying one RNA species, weaving connections across distinct categories, such as mRNA,
tRNA, and rRNA. Our experimental tests have validated this expansive insight and created a groundbreaking
coregulation hypothesis. If substantiated and refined, it will be a further conceptual contribution that promises
to reshape our understanding of RNA modifications, exerting influence over the depositions and ramifications
of multiple RNA alterations. With a foundation built on our past achievements, our overarching objective is to
delve deeper into the collective impacts and regulatory mechanisms orchestrated by multiple enzyme-
mediated modifications in distinct RNA species, particularly in gene regulation. In our proposed research, we
strategically chose two directions: investigating mRNA and tRNA modifications in one path and exploring
mRNA and rRNA modifications in another. This deliberate choice aims to uncover the extent of crosstalk in
translation, probing whether the collective impacts of modifications in distinct RNA species exhibit nonlinearity
and surpass the simple sum. We employ various methodologies to conduct these fundamental experimental
investigations, drawing from biochemistry (including enzymology), molecular biophysics, RNA biology, and
structural biology. Whether or not the crosstalk between modification of distinct RNA species is a collective
impact or a nonlinear effect of coregulation, our research outcomes will transcend the current focus on
isolated RNA species; we seek to offer a holistic view of the intricate impact of enzyme-mediated RNA
modifications in gene regulation—a landscape meticulously guided by genetically coded proteins.

Public health relevance
Project Narrative Messenger RNA, transfer RNA, and ribosomal RNA all carry enzyme-mediated modifications, which are critical for many RNA processing steps, and dysregulation of RNA modification status is linked to disease states. This project aims to understand the collective impacts and regulation mechanisms of multiple enzyme- mediated modifications in distinct RNA species in gene regulation beyond focusing on modification(s) in single RNA species in isolation.